Shared Resource 14: Proteomics (PSR)

PROJECT SUMMARY – PROTEOMICS SHARED RESOURCE (PSR)
The PSR provides expertise and access to state-of-the-art instrumentation for proteomics experiments. The PSR
is embedded within the OSU Campus Chemical Instrument Center, offering competitive pricing and exceptional
service by leveraging generous support from the Office of Research and Colleges, and grants from the NIH.
During the last review, the PSR was rated Outstanding as part of the Analytics Shared Resource Group, with
three addressable comments to reduce turn-around time, a perceived drop in percent users actually due to an
increase of non-cancer users as an OSU facility, and perceived duplicative services. Major services include: 1)
consultation for sample preparation, MS experiment design, data analysis, and timelines; 2) protein identification
using state-of-the-art MS on a variety of sample matrices; 3) in depth protein characterization including, but not
limited to, post-translational modifications, protein variant/mutations, protein truncation sites detection, alternate
splice form detection, de novo protein sequencing, protein cross-linking, and protein-protein interactions; 4)
protein quantification using label-free (spectral counts and/or relative intensity) or stable isotope label techniques
(SILAC or ITRAQ/TMT), quantitative MALDI tissue imaging, and targeted mass spectrometry; and 5) data
analysis provided with the BISR using commercial and in-house developed software platforms. Major equipment
has been enhanced in the past 5 years through three NIH S10 grants and a funded P41 Resource Center for
methods development. PSR Specific Aims are to: 1) provide advanced mass spectrometry-based proteomics
services; 2) provide innovative proteomic data analytics and bioinformatics platforms to facilitate user
interpretation; and, 3) provide consultation on experimental design and training on self-operated MS instruments.
Over the current funding cycle, the PSR provided key services in support of 44 publications (5 > 10 impact
factor), 380 users, and 8 NCI grants, including 1 K22, 1 P01, 4 R01s, 1 R33 and 1 U01. The PSR is critical to
the OSUCCC research priorities of immuno-oncology, translational genomics, cancer engineering and cancer
prevention and survivorship. Advanced analytical platforms allow researchers to discover novel differentially
expressed proteins in serum, urine, BAL fluid, saliva, frozen tissues, formalin fixed tissues, cell culture media,
and cell lysates. Given the robust OSUCCC recruitment, demand for services and new technologies will
increase. The GSR will expand its staff, instrumentation and services before capacity is reached. To address
this, planned new services are being implemented or expanded (informatics services with BISR, capillary
electrophoresis and ion mobility methods, tissue imaging, and structural biology using native MS, as developed
by a P41 Resource grant). Over the next funding period, the PSR will be a member of the Immune Monitoring
and Discovery Platform. The annual budget of the PSR is $1,993,101, yet the CCSG request is $158,381. Thus,
the PSR leverages extensive institutional support and seeks only 7.9% support from CCSG funds.